Therapeutic strategies to improve function of high risk liver grafts

PROJECT SUMMARY
This proposal presents a five-year research career development program focused scientifically on improving the
viability of liver grafts from extended criteria donors (ECD) for transplantation. The candidate is currently an
Assistant Professor of Surgery at Duke University. The candidate has previous research and clinical experience
in transplant surgery involving normothermic machine perfusion (NMP), whereby an organ is housed in an ex
vivo environment and perfused with nutrients and oxygen under physiologic conditions. The candidate will now
advance this technology by using NMP to deliver novel therapeutics to transplant grafts, and focus his research
on mitochondrial contributions to graft dysfunction. The candidate has assembled a diverse mentoring committee
of investigators with expertise in transplant surgery, NMP, molecular therapeutics, and mitochondrial biology.
The proposed training and experiments will provide the candidate with a combined skillset in innate immunity,
mitochondrial biology, transplant surgery, and biostatistics that will enable him transition to research
independence as a surgeon-scientist dedicated to reducing the organ shortage in the field of transplant surgery.
The primary obstacle facing the field of liver transplantation is the severe shortage of donor organs. In 2018,
8,000 liver transplants were performed in the United States, but another 13,000 patients remain on the waitlist.
The mortality rate of patients on the waitlist is exceedingly high, at over 20% per year. One strategy with great
potential to increase organ availability is utilization of extended criteria donors (ECDs). The ECD designation
includes donors of advanced age (≥ 60 years), those with significant hepatic steatosis, and livers donated after
cardiac death. However, widespread use of ECD livers has been limited by several factors, including increased
rates of graft dysfunction, graft failure, and recipient death. These poor outcomes have been attributed to a
reduced capacity of ECD livers to recover from ischemia-reperfusion (I-R) injury. I-R injury induces mitochondrial
dysfunction in the graft that leads to cell death. The dying cells in the graft release a broad array of molecules
known collectively as damage-associated molecular patterns (DAMPs), which are known to activate
inflammatory and cell death pathways, leading to further graft injury. We hypothesize that reducing the damage
caused by mitochondrial dysfunction and DAMPs will improve the viability of ECD livers for transplant and reduce
the current shortage of livers available for transplantation. The use of NMP technology provides an ideal platform
for delivering therapeutics to improve ECD graft function. This project will employ NMP technology to deliver
therapeutics that enhance mitochondrial function and removing harmful DAMPs using our novel DAMP-capturing
membrane. The aims of this proposal are: 1) determine the effects of enhanced mitochondrial function on ECD
liver transplantation, 2) determine the effects of removing DAMPs on post-transplant graft injury and function.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT The primary obstacle facing the field of liver transplantation is the severe shortage of donor organs. This proposal will explore strategies for improving the viability of extended criteria donor (ECD) livers (donors of advanced age, those with significant hepatic steatosis, and livers donated after cardiac death), which has tremendous promise to reduce this shortage. The studies in the proposal will use rat models of ECD liver transplantation to examine the impact of interventions to reduce mitochondrial dysfunction and inflammatory injury from damage-associated molecular patterns (DAMPs).